Stroke Preclicinal Assessment Network

Exploratory animal data on potential stroke therapies has not been predictive of clinical success. There
are concerns over the design and conduct of pre-clinical studies, their reproducibility and generalizability. The
response to this challenge was the NINDS Stroke Preclinical Assessment Network (SPAN), an unbiased
multicenter platform for preclinical confirmatory studies in translational stroke research. The MGH team was
among the six laboratories selected by the peer review for this first iteration of SPAN (SPAN-1).
We made major contributions to the design of SPAN-1. MGH took charge of the MRI protocol for
SPAN-1 and helped develop a fully automated analysis pipeline. We then contributed almost 400 animals in
under 2 years to test six different acute stroke interventions. Each animal underwent two MRIs (days 2 and 30)
and two neurological tests (days 7 and 28). Overall mortality was only ~10% during 28-day survival. Our
technical losses amounted to just 17 animals. There were only 3 protocol deviations or violations. Our
overarching aim is to repeat this success in the next iteration of SPAN (SPAN-2).
We are an experienced team of clinical and basic scientists capable of adjusting to the needs of the
network. MGH SPAN team has collectively published over 100 manuscripts using various focal cerebral
ischemia models and acute and chronic neurological outcome readouts in rodents. MGH will also bring
additional innovative approaches to SPAN-2, such as introducing MRI readouts for hemorrhagic
transformation, blood-brain barrier (BBB) disruption and tractography. We will complement the latter with
optical imaging of resting state functional connectivity (RSFC) at the end of the follow up period.
Aim 1. Contribute to SPAN-2 as a testing laboratory. We pledge to repeat our success in SPAN-1,
working as a team with the rest of the network and sustaining our high standards with built-in redundancies to
ensure our resilience in the face of personnel changes and disruptive events such as pandemics and weather.
Aim 2. Introduce innovative new structural and functional indices to enrich the SPAN readouts. We will
go beyond recruiting subjects for the trial by introducing innovative readouts such as hemorrhage, edema,
structural and functional connectivity, and histological analyses, which have not been part of SPAN-1.
Aim 3. Test whether an unbiased, multicenter, randomized, and blinded preclinical trial network can
confirm or refute the published exploratory efficacy and safety data. We hypothesize that SPAN will have the
statistical power and an unbiased structure to provide conclusive evidence confirming or refuting published
exploratory data of prospective cerebroprotective therapies in ischemic stroke in combination with reperfusion.
For over a decade, we have advocated for and passionately supported the concept of an unbiased
multicenter preclinical testing platform. We enthusiastically worked as part of SPAN-1 to ensure its success.
And now we are fully committed to support SPAN-2 to make it a success as well.

Public health relevance
Project Narrative Exploratory animal research in stroke therapy development has not been predictive of clinical success. There are concerns over the design and conduct of pre-clinical studies, their reproducibility and generalizability. This proposal aims to help establish and contribute to a preclinical trial platform in acute ischemic stroke to overcome the translational roadblock.